The epigenetic reader BRWD1 in peripheral adaptive immunity

PROJECT SUMMARY
Recently, we demonstrated that the lineage-restricted BROMO and WD40 domain containing epigenetic reader
BRWD1 opens Igk and induces an epigenetic landscape that enables assembly of RAG proteins at Jk. We now
report that BRWD1 has a much broader role in late B cell development. BRWD1 reshapes chromatin landscapes
by closing enhancers of genes expressed early in B cell development and opening those of genes expressed in
late stages. BRWD1 did not affect the expression of critical transcription factors (TFs). Rather, as demonstrated
for IRF4, BRWD1 determines the sites they bind across the genome. BRWD1 differentially regulated over 7000
genes, repressing proliferative and inducing differentiation programs. Notably, BRWD1 coordinately repressed
Myc and Myc target genes. Furthermore, in humans, BRWD1 mutations are associated with
hypogammaglobulinemia. These data indicate that, in both mice and humans, BRWD1 is a master orchestrator
of enhancer accessibility that cooperates with TF networks to drive late B cell development.
BRWD1 is first expressed in small pre-B cells. However, Brwd1 expression is higher in naïve follicular (FO)
and in germinal center (GC) dark zone (DZ) cells. Analysis of genes differentially expressed in GC DZ and light
zone (LZ) cells, compared to those differentially regulated by BRWD1 in small pre-B cells, predicts that BRWD1
represses the DZ program and induces the LZ program. Furthermore, differential genome-wide binding of
BRWD1 in DZ and LZ cells suggests different functions in each GC subset. Immunizing Brwd1fl/fl x Aicda (AID)-
Cre mice revealed that BRWD1 was required for normal antibody isotype switching and affinity maturation.
Histologically, GCs were greatly reduced in both size, and number, and lacked follicular dendritic cells. Therefore,
we hypothesize that BRWD1 regulates epigenetic states and enhancer landscapes critical for coordination of DZ
and LZ transcriptional programs and GC function. We will test this hypothesis in the following Specific Aims:
Aim 1. Determine the transcriptional regulation of normal germinal center responses.
Aim 2. Determine the role of BRWD1 in adaptive immunity.
Aim 3. Determine the role of BRWD1 in initiating GC responses and in maintaining FO B cell identity. !

Public health relevance
PROJECT NARRATIVE Humoral immunity is critical for fighting infection and the efficacy of vaccines. In this grant application, we will define a novel layer of gene regulation that coordinates with transcription factors to regulate B cell responses to antigen.